Evaluation of a novel intervention to prevent polysubstance overdoses involving illicit stimulants

Project Summary
Overdoses involving illicit stimulants are increasing in the United States (US). Many of these overdoses involve
fentanyl, which may be added to illicit stimulants with or without the user’s knowledge. Given the potency of
fentanyl and its pervasiveness in the illicit drug supply, any meaningful efforts to reduce overdose deaths
involving illicit stimulants must also address fentanyl. Rapid fentanyl test strips, designed to test for the
presence of fentanyl and some fentanyl analogs in urine samples, are increasingly being used off-label by
people who use drugs to test illicit drugs for fentanyl before consumption. This alerts the user that they may
wish to perform overdose risk reduction behaviors (e.g., using less of the drug). However, due to the emergent
nature of this harm reduction strategy, peer-reviewed published research on this topic is very limited. The
proposed study addresses Objective #1 of the NOFO and will test an intervention to prevent overdoses among
a high-risk population of drug court clients with a history of illicit stimulant use. The intervention consists of 1)
fentanyl test strip education and distribution (FTSED) and 2) opioid overdose education and naloxone
distribution (OEND) through drug courts in Ohio. The long-term goal of this research is the reduction of
overdose-related morbidity and mortality in Ohio and nationally. The research objectives of this study are: 1)
Determine the acceptability and feasibility of providing FTSED and OEND on-site through drug courts (process
evaluation – Specific Aim #1); and 2) Evaluate the impact of providing FTSED in combination with OEND to
drug court clients who use illicit stimulants or polysubstances including illicit stimulants, compared with
providing OEND alone (outcome evaluation – Specific Aims #2 & #3). Using a two-arm group randomized trial
design, we will answer the research objectives by testing the following specific aims: 1) Determine the
perceived acceptability, barriers, and facilitating factors associated with providing FTSED and OEND on-site in
drug courts to clients who use illicit stimulants or polysubstances including illicit stimulants; 2) Test the
hypothesis that individuals with a history of illicit stimulant use who receive FTSED and OEND on-site in drug
courts will have improved knowledge and self-efficacy regarding how to test drugs for fentanyl and strategies
for reducing their risk of an overdose compared to those who receive OEND only; 3) Test the hypothesis that
individuals with a history of illicit stimulant use who receive FTSED and OEND on-site in drug courts will have
lower non-fatal and fatal overdose rates associated with illicit stimulants or polysubstance use involving illicit
stimulants than those who receive OEND only. Given the pervasiveness of fentanyl in the illicit drug supply,
even individuals whose preferred drugs are illicit stimulants are likely to encounter fentanyl and/or fentanyl
analogues. We will evaluate the feasibility, acceptability, and associated benefits and harms of integrating
FTSED into drug court programs in a state with high rates of overdoses involving stimulants.

Public health relevance
Project Narrative The proposed collaborative research intervention will evaluate the acceptability, feasibility, and associated impact of integrating fentanyl test strip education and distribution and opioid overdose education and naloxone distribution into drug courts in Ohio to prevent overdoses from illicit stimulants and polysubstances including illicit stimulants. Given the pervasiveness of fentanyl in supplies of illicitly manufactured stimulants and other drugs, more public health entities in the United States are supporting fentanyl test strip education and distribution as a promising harm reduction strategy, but research supporting the intervention is limited. We expect that the findings of this study will advance the existing scientific knowledge related to fentanyl test strip education and distribution and inform decisions by public health and criminal justice leaders and policy makers on whether to support the continuation and expansion of fentanyl test strip education and distribution in Ohio and nationally.